Germline Transformation of Ticks

PROJECT SUMMARY
Ticks and the pathogens they transmit incur significant costs to public health and agriculture worldwide.
For instance, Ixodes scapularis, the primary vector of Lyme disease (LD) in the United States, is responsible
for over 300,000 LD cases annually. The economic losses due to Rhiphicephalus (Boophilus) microplus are
two-fold: reduced body weight and milk production in cattle and the treatment cost employed to prevent
disease and control ticks. Increased incidence and distribution of ticks and tick-borne diseases necessitates a
better understanding of vector biology to develop new approaches for tick control. Recent advances in genetic
transformation techniques, esp. CRISPR/Cas9 system has immensely facilitated functional genomics studies.
These advances now allow the elucidation of gene functions in non-model organisms such as ticks. However,
because of the unique biology of ticks, several technical hurdles have prevented gene-editing from being
applied to study tick molecular biology, most notably lack of an embryo injection protocol and understanding of
the early embryonic events. We overcame significant impediments through our R21 grant by developing
embryo injection protocols and the first proof-of-principle tick gene knockout. However, no heritable insertions
have been observed in ticks yet. It is essential to inject eggs at the right time so that introduced material can
access the nuclei of the future germ cells (before cellularization) and create stable germline transformants.
CRISPR/Cas9 uses a guide RNA complementary to the target DNA and directs DNA cleavage by the
Cas9 endonuclease. Modification of the genome sequence occurs during double-stranded break (DSB) repair,
and the molecular pathways that come into play determine the type of sequence change. Canonical
nonhomologous end-joining (cNHEJ) and alternative end-joining pathways such as micro-homology-mediated
end-joining (MMEJ) proceed by ligation of DNA ends and result in targeted but imprecise edits (generally small
insertions or deletions) resulting in gene knockout. However, microhomologies of two or more nucleotides
exposed after DNA cleavage through resection could be used for precise editing during repair by MMEJ.
Homology-directed repair (HDR) uses an exogenous DNA repair template that supports precise genome editing.
Our previous work suggests that ticks frequently use MMEJ pathways for DSB repair. In this proposal, we will fill
our knowledge gaps by first understanding the timing and site of primordial germ cell formation using known
markers as well as utilizing the single-cell RNAseq technique to better understand the gene expression during
early embryonic development (Aim 1). We will then leverage our previous findings to generate germline-edited
ticks by developing Vasa-Cas9 lines for efficient and accessible knockout studies. We will compare the
efficiencies of MMEJ and HDR for knock-in experiments to integrate transgenes (Aim 2). The expected outcomes
of our work will provide new tools to determine the genetic basis of many tick phenotypes, including those
involved in pathogen transmission.

Public health relevance
Ticks are obligate hematophagous arthropods and ecto-parasites of every class of vertebrates in almost every region of the world. Despite the increasing information available on ticks, there is lack of molecular tools to understand the basis of tick phenotypes and tick-pathogen interactions. This proposal focus on understanding tick biology on molecular level by developing genome editing tools.